Ohio State University Discovery PREP for Biomedical Research

ABSTRACT:
Diversity in the biomedical research workforce is necessary to solve the complex scientific problems that affect
society today. Diversity improves research quality and diverse teams are known to capitalize on innovation and
distinct perspectives to outperform non-diverse teams. Yet, individuals from certain groups remain
underrepresented in biomedical research. This provides the scientific community with an opportunity to enhance
the biomedical research workforce by increasing the diversity of participating individuals and improve research
efforts. The career transition between undergraduate and graduate school can be especially difficult to navigate.
The goal of Discovery Postbaccalaureate Research Education Program (PREP) is to provide individuals from
diverse backgrounds with robust research experience and courses/workshops for skills development to promote
their transition into and success within biomedical PhD graduate programs. Discovery PREP was initiated in
2010, renewed in 2016, and has consistently received strong institutional support in terms of participant salary,
travel funds, test preparation, and programmatic support. The overall success of the program is good, with 84%
of scholars accepted into PhD graduate programs while within PREP since 2016. This competitive renewal seeks
to leverage recent successes and increase scholar training and support, through hands-on exposure and
mentoring in highly competitive laboratories, evidence-informed activities to support professional and personal
skills development, and summative and formative evaluations to establish the impact of the program on scholar
science self-efficacy, science identity, and sense of belonging within the academic research enterprise. Overall,
these efforts will create a cohort of passionate, effective, and highly skilled trainees that will enhance the diversity
of the scientific community and promote innovative solutions to address the tough scientific challenges in health
care today.

Public health relevance
Diversity in the biomedical research workforce improves research quality, promotes strong learning environments, fosters scientific innovation, and increases the likelihood that health disparities are addressed. Discovery PREP promotes the success of underrepresented trainees working to become biomedical scientists by fostering development of the technical and professional skills which promote excellence in scientific research and graduate school.